SIRPgamma: a novel checkpoint regulator of effector responses from human T-cells

Abstract
A key unresolved question in immunology is: why do some individuals mount a
balanced immune response that eliminates infection with no harm to host cells,
whereas others have exaggerated immune responses that can cause significant tissue
injury and precipitate autoimmunity? This question raises an unprecedented need to
better understand the host mechanisms involved in fine-tuning immune responses in
humans. T cells play a critical role in shaping a balanced immune response to antigens
by directly recognizing molecules expressed on the cell surface and secreting factors
that drive or dampen the inflammatory responses. Signal regulatory protein gamma
(SIRP) is an immunomodulatory protein that is uniquely expressed on the cell surface
of human T cells. Variants in the SIRPG gene have been associated with type 1
diabetes, relapsing remitting multiple sclerosis and maintaining a vaccine response
long-term. However, how SIRP mechanistically contributes to inflammation remains
unclear because we do not fully understand its function in the immune system. The
overall goal of this research is to understand whether inter-individual differences in
SIRP expression regulates the effector responses in human T cells. Previously we
found that an autoimmunity risk variant in SIRP correlates with reduced expression of
SIRP on the T-cells, and that T cells with less SIRP on the cell surface exhibit
heightened effector status. This exciting discovery suggest that perturbations in SIRP
levels may lead to immune dysregulation during infections and autoimmunity. To test
this we will investigate whether intrinsic dysregulation in SIRP expression on naïve T
cells accelerates their conversion into terminal effectors, thus driving hyper-
proinflammatory responses. These studies will determine if SIRP plays a causative
role in determining the magnitude and nature of effector responses from T cells. Given
the association of SIRP with multiple autoimmune diseases and vaccine response,
understanding the role of SIRP in immune regulation could significantly impact
treatment in infection and autoimmunity.

Public health relevance
Project Narrative Despite extensive research, it is still not known why do some individuals mount an exaggerated inflammatory response during an infection or toward their own self- antigens. This research will investigate whether inter-individual differences in Signal Regulatory Protein Gamma (SIRP) expression, a protein that is epressed on the T-cells in humans, regulates the magnitude and nature of inflammatory responses in humans. Given the association of SIRP with multiple autoimmune diseases and vaccine response, understanding the role of SIRP in immune regulation could significantly impact treatment in infection and autoimmunity.